How infectious SARS-CoV-2 exploits two ER membrane proteins to promote infection

Abstract
SARS-CoV-2 exploits the function of the endoplasmic reticulum (ER) to promote its
infection life cycle. Despite its strong reliance on the ER, the molecular basis by which
SARS-CoV-2 hijacks ER factors to promote defined steps of this life cycle remains
unclear. Using infectious SARS-CoV-2, we recently identified two ER membrane
proteins – RTN3 and SigmaR1 – as critical host factors that support virus infection. Our
findings further reveal that RTN3 plays a role in viral replication, while SigmaR1 exerts a
function in viral secretion. However, how SARS-CoV-2 exploits the activities of RTN3
and SigmaR1 to accomplish these two distinct tasks, in mechanistic terms, is completely
unknown. Accordingly, the objective of this application is to elucidate the molecular basis
by which these two ER membrane factors promote replication and secretion of SARS-
CoV-2. We believe these insights will not only illuminate the basic infection mechanism
of SARS-CoV-2, but given the continuing global COVID-19 pandemic, may lead to the
development of effective anti-virals to blunt the devastating impact of SARS-CoV-2.

Public health relevance
Project narrative During infection, SARS-CoV-2 induces formation of an endoplasmic reticulum (ER)- derived organelle (called the double-membrane vesicle) to support replication of the viral genome, although the molecular basis of this process remains enigmatic. Upon assembly of the replicated genome with virus structural proteins, the newly-formed viral progeny undergoes secretion via a poorly-define mechanism. Accordingly, this application will elucidate how SARS-CoV-2 exploits two ER membrane host factors (RTN3 and SigmaR1) to promote viral replication and secretion, two essential infection steps.